Augmented Reality Platform for Telehealth Rehabilitiation

Efforts to keep the most vulnerable individuals with chronic medical conditions from being exposed to COVID- 19 have triggered an unprecedented decline in the number of visits to ambulatory practices. The repercussions have impacted not only those with the disease, but the many millions of older persons in need of healthcare who forego in-person visits in fear of infection or for socioeconomic reasons. While the precipitating need for alternative healthcare delivery methods has hastened the adoption of software solutions, such as Zoom, traditional videoconferencing services fail to compensate for the lack of direct physical evaluations with a patient that is needed for evaluating musculoskeletal (MSK) deficits, planning therapeutic interventions, and guiding exercise compliance—essential components of evidence-based practice among rehabilitation practitioners. To overcome these shortcomings, our team of computer vision and human movement engineers is partnering with orthopedic rehabilitation specialists at Massachusetts General Hospital (MGH) to develop a telehealth platform that fuses high resolution RGB and Depth (RGD-D) video data readily obtainable from a modern smartphone to facilitate quantitative, MSK assessment. The innovation builds upon our work in computing movement outcome measures from vision-based body tracking algorithms, and our skills in augmented reality (AR) software development to enhance a clinician’s assessment and exercise instruction capabilities. Our pilot data demonstrate that accurate quantitative rehabilitation outcomes are obtainable using RGB-D body tracking algorithms during a sub-set of knee activities. Phase I will advance these capabilities by deriving and validating the accuracy of 3D body tracking and rehabilitation outcome measures during a wider set of activities used clinically for assessing knee mobility, alignment, posture, balance, strength, and function from depth enabled smartphone video recordings in control subjects (Aim 1). Aim 2 will develop a proof-of-concept AR telehealth platform with the help of the MGH team that delivers an enhanced telehealth experience through real-time synchronized audio-visual processing, real-time display of quantitative rehabilitation outcomes for the therapist to assess deficits or guide exercise compliance, and instructional animations for the patient to safely carry out the rehabilitation activities. The proof-of-concept prototype will undergo feasibility testing in Aim 3 among n=5 physical therapists and n=10 patients with knee OA during a simulated telehealth session to achieve high ratings for usability, accessibility, and effectiveness. The results will inform the user-requirements of a more complete Phase II telehealth platform designed in close collaboration with industry partners to provide secure cloud based communication for seamless interoperability between devices; additional examination tools (e.g. gait analysis); a broader range of baseline assessment and therapeutic exercise protocols for additional MSK conditions; and HIPAA-compliant deployment and electronic documentation management. The final prototype system will be evaluated during actual telehealth visits at multiple clinical sites to promote safe and effective clinical care.

Public health relevance
PROJECT NARRATIVE With the onset of the COVID-19 pandemic, clinical care has by necessity shifted towards telehealth delivery for people at risk due to age, who live in underserved communities or avoid in-person visits out of fear of viral transmission. Existing telehealth software platforms are generally supportive of videoconferencing but have yet to provide rehabilitation professionals with quantitative outcomes typically obtained from direct physical evaluations with a patient. To overcome this shortcoming, we are developing an augmented reality platform that fuses RGB and depth imaging from a patient’s smartphone to deliver quantitative outcomes of knee joint mobility, alignment, posture, balance, strength and function during a telehealth visit to support the mandate for more effective remote delivery of evidence-based rehabilitation during the global pandemics and beyond.